Vectored delivery of anti-HIV antibodies for mucosal protection

Project Summary/Abstract
The poor immunogenicity of the HIV envelope spike and its vast variability represent major obstacles for efficient
elicitation of protective anti-HIV antibodies. One promising strategy is to bypass the immune system and deliver
already known and well-characterized potent and broadly neutralizing antibodies directly to the host. However,
periodic administrations of large amounts of protein would be required for long-term effects. Recombinant adeno-
associated virus (AAV) vectors have been widely used for gene delivery applications because of their safety and
cost-efficiency: one single injection can account for long term expression of the transgene. The use of AAV
vectors would bypass the need for periodic administrations of antibody and, as long as the delivered protein is
viewed as self, it can result in continuous durable expression. Studies in monkeys and in mice have already
shown the extreme promise of AAV for this antibody delivery approach against HIV, and pioneer human trials
have demonstrated its safety and feasibility. However, only antibodies in IgG form (monomeric immunoglobulin)
have been employed in such AAV-antibody delivery applications, while polymeric immunoglobulins (such as
dimeric IgA and pentameric IgM) have been overlooked, despite their desirable characteristics for mucosal
protection. In addition, little is known about what proportion of circulating AAV-delivered antibody gets transferred
to relevant viral entry points such as the rectal or vaginal mucosae and how that correlates with the level of
protection against mucosal exposure that can be achieved. Building up on our previous monkey trials, what we
propose here is to evaluate AAV-mediated delivery of a potent and broadly neutralizing antibody as different
immunoglobulin types and assess the degree of protection that can be achieved to mucosal viral challenge by
each type (Aim 1). We will use the highly relevant macaque model and quantitate in vivo AAV-produced antibody
in circulation and in the relevant mucosae. Our goal is to find what immunoglobulin type shows optimal transfer
of the AAV-delivered antibody to the viral point of entry in mucosae and/or optimal protection against challenge.
Because HIV is mainly transmitted sexually, our findings will be highly relevant in the fight against HIV
transmission. Our overall goal is to inform and guide development of the AAV-antibody concept for its use in
people.

Public health relevance
Project Narrative Broadly neutralizing antibodies delivered in ‘IgG form’ with recombinant adeno-associated virus (AAV) can mediate protection against HIV/SHIV acquisition in animal models. However, little is known about alternative immunoglobulin types such as IgA and IgM, and/or the amounts of AAV-delivered antibodies that are able to reach the main viral entry points: the rectal and vaginal mucosa. In this project we will tackle these key matters and assess 1) mucosal levels, and 2) protection that can be afforded by different immunoglobulin types, when delivered with AAV.